BASE YEAR: DATA COMPUTING SERVICES FOR DCP

This requirement provides computing services to the Division of Cancer Prevention, divided into six fully integrated and cohesive task areas:

Task Area 1. Project Management/Core Services
Task Area 2. Data Management
Task Area 3. Computer Programming
Task Area 4. Computing Infrastructure Services
Task Area 5. Website Development
Task Area 6. Systems Design and Development